Contractile Pericyte-Mediated Cerebrovascular Deficits in a Mouse Model of CADASIL

CADASIL (Cerebral Autosomal Dominant Arteriopathy with Subcortical Infarcts and Leukoencephalopathy) is the
most common monogenic form of small vessel diseases (SVDs) which underlie a large portion of vascular
cognitive impairment cases and a quarter of all stroke cases. Despite the identification of mutated NOTCH3 as
the site of pathology in two vascular cell types, endothelial cells (ECs) and smooth muscle cells, there is currently
no cure for CADASIL. Surprisingly, a third vascular cell type—pericytes—are virtually unstudied in the context of
CADASIL, despite ample expression of NOTCH3 protein and known roles in the control of cerebral blood flow
(CBF), which CADASIL patients exhibit early deficits in. Pericytes are found in the brain surrounding capillaries
and at least two forms of pericytes exist along distinct sections of the capillary tree. Contractile pericytes, one
such subtype, are located on the capillaries initially branching from the penetrating arterioles (PAs) that dive into
the brain parenchyma. Contractile pericytes can contract and relax rapidly to directly regulate capillary diameter
and thus modulate blood flow delivery to the downstream capillary tree. Pericyte contraction is in turn regulated
by membrane potential, which ECs can modulate via transcellular communication through gap junctions that can
be found in pericyte invaginations into EC membranes known as peg-and-socket junctions. Contractile pericyte
hyperpolarization collectively lowers Ca2+ levels which leads to contractile pericyte relaxation and dilation of the
underlying capillary. Our preliminary data indicates that contractile pericyte-mediated control of blood flow is
impaired earlier than other known CBF deficits in a classically used mouse model of CADASIL, thus pericytes
could be a target for early clinical intervention. Intriguingly, we observed that other mechanisms of pericyte blood
flow control are intact at this early timepoint despite diminished blood flow and capillary diameter responses to
EC hyperpolarization in capillaries covered in contractile pericytes. Our data strongly suggests that contractile
pericytes are unable to respond to capillary electrical signaling to induce membrane hyperpolarization. As gap
junctions between ECs and contractile pericytes control communication of signals between these cells, I propose
to elucidate whether EC-contractile pericyte gap junctions are altered in CADASIL and the downstream
ramifications of this disruption with pharmacological and optogenetic interventions in a transgenic mouse model
of CADASIL. To achieve this, I will use two-photon laser scanning microscopy in awake mice, a capillary-
parenchymal arteriole (CaPA) ex vivo preparation, electron microscopy, and electrophysiology, all to measure
perturbations of normal contractile pericyte physiology in this disease context. This work will provide novel insight
into a potential early-stage pathogenic mechanism of an early marker of CADASIL, positioning contractile
pericytes as a target of intervention to halt debilitating disease phenotypes. The training obtained under this
fellowship will provide deep and diverse training in the methodologies and professional development necessary
for my future success as an academic researcher at a biomedical institution.

Public health relevance
Project Narrative CADASIL (Cerebral Autosomal Dominant Arteriopathy with Subcortical Infarcts and Leukoencephalopathy) patients often experience strokes and cognitive impairment, and while disease causing mutations in the protein NOTCH3 have been studied deeply in brain blood vessels, a key cell type that envelops brain blood vessels known as the pericyte is virtually unstudied in this disease despite ample NOTCH3 presence. The goal of this proposal is to improve our understanding of pericyte contributions to early brain blood flow deficits seen in this disease as pericytes contribute to multiple blood flow control mechanisms. Determining the role that pericytes play in disease progression can lead to identification of targets for early therapeutic intervention.